CHIMERIC DNA POLYMERASE--CONSTRUCTION &CHARACTERIZATION

We will construct, express and characterize a set of hybrid recombinant DNA polymerases will possess a highly processive 5' -3' DNA polymerase activity derived from the large domain of T3 bacteriophage gene 5 and a moderate 3' -5 exonuclease activity derived from the small domain of the Klenow fragment. This will be accomplished using a novel chimeric construction/expression vector developed at Stratagene. The vector will allow the rapid generation of four chimeric constructs each having a different transition site between the DNA sequences encoding the 3' -5 exonuclease activity of the Klenow fragment and the DNA sequences encoding the 5' -3' T3 DNA polymerase activity. The chimeric polymerases will be a useful molecular biology reagent in circumstances which require a high degree of processivity and fidelity during the DNA polymerization reaction. Potential applications involve the improvement of site-specific mutagenesis reactions, DNA sequencing and amplification of large genes. In addition to engineering these hybrid polymerase constructs, the methodologies developed in Phase I of this proposal will provide valuable model system to researchers for future hybrid protein constructions. In Phase II of this proposal, the experience gained from the methodologies, construction and analysis of the recombinant polymerases will be applied to engineer other multifunctional enzymes with important industrial, pharmaceutical and molecular biology applications.